Molecular Mechanisms of Viral Entry by Membrane Fusion

PROJECT SUMMARY
Membrane fusion, mediated by viral spike glycoproteins, is a key process in the infection cycle of all
enveloped human and animal viruses. The overall goal of this project is to understand the molecular
mechanisms of Ebola and human immunodeficiency virus entry by membrane fusion, by taking
combined state-of-the-art structural and cell biophysical imaging approaches. Although the crystal
structures of the ectodomains of several enveloped virus spike glycoproteins have been determined to
high resolution and although we and others have contributed NMR structures of the membrane-
interactive parts of some of these proteins over the years, we are only beginning to understand the
structural transformations that take place when these protein domains interact with membranes and
each other, and how these structures drive membrane fusion. In the previous grant period we have
made substantial progress towards elucidating the structures of the fusion loop, membrane proximal,
and transmembrane domains of the Ebola virus envelope glycoprotein and their pH-dependencies in
membrane environments. We have also discovered that HIV particles bind and fuse preferentially at
lipid discontinuities in plasma membranes of infected cells and that this process depends critically on
the level of membrane cholesterol. Building on these achievements, we now propose to (1) solve the
structure of the Ebola virus fusion loop in interaction with its membrane-proximal and transmembrane
domain, (2) determine the intracellular factors that trigger Ebola virus fusion in the late endosome, and
(3) determine the role of membrane heterogeneity in forming the fusion pore for HIV entry.

Public health relevance
PROJECT NARRATIVE Viral infections cause many devastating diseases in the US and abroad. Many viruses including influenza, Ebola, and human immunodeficiency viruses, are enveloped by a membrane that encloses their hereditary nucleic acids. To propagate these viruses infect cells by fusing their membrane envelopes with a target membrane of the cell either at the cell surface or in an internal organelle, i.e. the endosome. This project aims at discovering the fundamental mechanisms by which Ebola virus and HIV fuse with their respective target membranes. State--of--the--art structural, biophysical, and high- -resolution imaging approaches will be taken to delineate the cell entry mechanisms of these two viruses. Knowledge gained from this research will help to eventually develop new classes of viral entry inhibitors.